Molecular Mechanisms of Tonotopy Development in the Brain Stem

ABSRACT
Normal nervous system maturation is dependent on neurotrophin signaling. Neurotrophins are proteins, and
along with their signaling receptor pathways, help regulate the development, maintenance and function of
vertebrate nervous systems, making it a dynamic factor that promotes biologically relevant tasks. Irregular
neurotrophin signaling results in pathophysiological conditions throughout the peripheral and central nervous
system. In the auditory periphery for example, this includes atypical arrangement of innervation patterns along
the frequency gradient (i.e., tonotopic axis) of the inner ear and hearing loss. Beyond the auditory periphery of
all vertebrates, however, the establishment of functional specialization in the central auditory pathway via
neurotrophin signaling are lacking. Understanding gradients of neurotrophin signaling is a significant and timely
problem in developmental neurobiology in general, and the avian auditory pathway proves to be a particularly
advantageous model system for experimentally examining it. A better understanding of normal auditory circuit
assembly – along with the unique functional properties of brainstem neurons – will provide a significant
foundation for developing stem cell-based therapies for auditory-related disorders. Stem cell-derived auditory
neurons will only prove useful, therapeutically, if they are able to re-create specialized functional properties that
are characteristic of normal auditory circuit maturation. A careful characterization of neurotrophin signaling, the
underlying molecular mechanism by which they operate, the role it plays in establishing normal auditory
properties and the functional consequence of altering this biological process is necessary and appropriate. The
research proposed here aims at addressing these issues by providing a comprehensive understanding of
developmental properties associated with neurotrophin signaling and its role in establishing normal functional
phenotypes along the tonotopic axis in the cochlear nucleus: a brainstem structure essential for the temporal
processing of sound.

Public health relevance
PROJECT NARRATIVE Neurotrophins and their signaling receptors are proteins that help regulate the development, maintenance and function of vertebrate nervous systems. Fundamental to this is the role neurotrophin signaling plays in establishing normal structure and function during neuronal auditory ontogenesis. This R01 proposal focuses on the characterization, mechanisms and functional consequences of neurotrophin signaling in the auditory system. Research proposed will delineate the regulation, structure-function relationships, genotype-phenotype correlations, and deviations in neuronal properties in the developing auditory brainstem.